Vaccine and Treatment Evaluation Units: Phase IV Clinical Trial in Adults with Community Acquired Pneumonia to Assess the Effect of Early Empiric Antifungal Treatment of Coccidioidomycosis Pneumonia

This program is comprised of a consortium of individual contracts within academic centers and organizations that provide a ready resource for the design and conduct of clinical trials to evaluate promising products to combat infectious diseases. In general, products will be evaluated in normal healthy populations; however, access to special populations is also available.